3D wearable NIR spectral tomography for early prediction of breast cancer’s residual cancer burden after neoadjuvant chemotherapy

Prediction of Residual Cancer Burden (RCB) early in treatment can enhance long-term survival outcomes for
breast cancer patients undergoing neoadjuvant chemotherapy (NAC) and their long-term survival.1-3 Near-infra-
red spectral (NIRS) tomography (NIRST) provides operational advantages over other imaging technologies (e.g.,
mammography, ultrasound, Magnetic Resonance Imaging (MRI), CT, Positron Emission Tomography) in the
NAC setting because it is noninvasive, portable, low cost, and does not use ionizing radiation or exogenous
contrast agents. Crucially, NIRS captures biophysical changes in tissue occurring in the vascular, intra- and
extra-cellular matrix compartments. These subtle changes signal a tumor's early response to NAC, even before
visible tumor size modifications occur.4-7 Compared to other optical imaging modalities that use reflectance light,
which limits tissue imaging depth8, 9, or require high-power lasers posing safety risks10, NIRST captures diffused
tomographic signals, allowing for deeper breast tumor sensing. In our previous studies, we have pioneered a
NIRST system that quantifies vascular changes in the breast during NAC, highlighting tumor response within
about two minutes as the patient sits in a semi-reclined position.11,12 This system correlates tumor NIRST
changes with clinical outcomes based on residual cancer burden (RCB) classification.13 Our clinical NIRST data
from 35 women on NAC persuades us of NIRST's potential to revolutionize the clinical approach to these patients.
This belief stems from recently published results which showcase the normalized percentage change of total
hemoglobin in a tumor (ΔHbT%) by the end of the first cycle as a compelling biomarker that discerns either
RCB-0 or RCB-II from all cases in other classes (p £ 0.001).13 A thorough multi-class Receiver Operating Curve
analysis offers an Area Under the Curve of 0.80, emphasizing the precision of ΔHbT% in distinguishing between
RCB classes. We envisage elevating our system's efficiency by integrating flexible circuit strips through a sleek,
wearable 64-channel breast interface and applying 3D image reconstruction that reflects full tumor response
(instead of partial tumor volume) – the focal point of our proposed Aim 3. Our previous data further indicate that
NIRST's diagnostic performance remains undiminished when relying solely on continuous-wave signals and
patient-specific scattering estimates derived from mammograms or MRI defined breast density.14 These insights
have shaped the hardware platform proposed in Aim 1. However, the current iteration of our NIRST system faces
challenges from its dependency on large-core fiber bundles for receiving light from the patient's breast. By phas-
ing out these cumbersome fiber bundles, we open avenues for novel 3D image reconstruction methods en-
hanced with deep learning—as set out in Aim 2. In essence, this project focusses on technological innovations
aimed at creating a comprehensive NIRST breast imaging platform, designed to forecast RCB in early stages of
NAC. Accordingly, we are transitioning this platform from academic exploration to a clinically practical solution,
while concurrently seeking additional funding to facilitate expansive clinical studies in the foreseeable future.

Public health relevance
PROJECT NARRATIVE Our project aims to refine a novel Near-infrared Spectral Tomography (NIRST) system for probing whether changes in tumor vasculature predict early neoadjuvant chemotherapy (NAC) responses. The rigor of prior re- search and the human data we obtained show the normalized change in tumor hemoglobin (ΔHbT %) after the first NAC cycle is a key indicator for classifying Residual Cancer Burden, with significant results in multi-class Receiver Operating Curve analysis (an area under the curve of 0.80). We will focus on the new technology developments that will elevate NIRST from a research tool to a fully functional clinical solution.